Individualized computational assessment of the effects of GABA receptor modulation in posttraumatic stress disorder

Posttraumatic stress disorder (PTSD) is among the most common mental health conditions among all
treatment-seeking Veterans, and the critical lack of advancement in pharmacological treatment of this disorder
has been termed an urgent crisis by leaders in the field. Progress in developing more effective treatments for
PTSD has been hampered by the substantial heterogeneity in this population. Research suggests that a deficit
in inhibitory gamma aminobutyiric acid (GABA) signaling may underlie a specific subgroup in PTSD
characterized by high anxious arousal relative to general negative affect. We propose a computational goal-
directed control paradigm as an objective clinical test based on the premise that a reduction in dynamic
inhibition, regulated by GABA signaling, can serve as a specific marker for a high arousal PTSD (HA-PTSD)
subgroup. Our study will leverage: 1) a single dose of a benzodiazepine as a robust, acute GABA receptor
modulator for phenotypic validation rather than treatment purposes; 2) a novel goal-directed control modeling
strategy to precisely measure the acute effects of GABA receptor modulation on dynamic inhibition; 3)
functional neuroimaging to assess specific neural mechanisms of GABAergic influence on dynamic inhibition.
Given heterogeneity in the PTSD population, a precision phenotyping approach is critical for assigning
specific treatments to Veterans most likely to benefit. This application seeks to develop a precision
phenotyping approach for Veterans with deficient GABA signaling, who would benefit from novel agents that
positively modulate GABA signaling. A crucial step is to validate the proposed phenotyping approach using a
benzodiazepine as a robust causal pharmacologic probe of the effects of GABA receptor modulation, before
subsequently deploying the phenotyping approach in future clinical trials of novel agents.
Our team has developed the rapid assessment of motor processing (RAMP) paradigm, a computational
goal-directed control task which enables precise estimation of a dynamic inhibition parameter. Compared to
other behavioral measures, dynamic inhibition exhibits excellent measurement reliability. Dynamic inhibition is
negatively associated with subjective fear, and this relationship persists after controlling for general negative
affect. Critically, dynamic inhibition is lower in a HA-PTSD subgroup (with high residual fear, controlling for
negative affect) compared to both a low arousal PTSD (LA-PTSD) subgroup and healthy controls (HC).
Dynamic inhibition is also associated with structure and function in arousal-related regions such as dorsal
anterior cingulate cortex (dACC) and insula.
The present application seeks to examine the effect of a single dose of the positive GABA modulator
lorazepam on dynamic inhibition in healthy controls (HC) as well as two subgroups of Veterans with PTSD: an
HA-PTSD group and an LA-PTSD group. We hypothesize that lorazepam will have a greater effect in
increasing dynamic inhibition in the HA-PTSD group compared to both HC as well as LA-PTSD, providing
evidence for a distinct biological mechanism in HA-PTSD. Furthermore, we hypothesize that the increase in
dynamic inhibition with lorazepam will be correlated with the effect of lorazepam in reducing activity in arousal-
related neural regions including dorsal anterior cingulate cortex (dACC), insula, and amygdala. We will test
these hypotheses in a crossover study in which each Veteran receives a single dose of lorazepam and placebo
in randomized order and performs the RAMP paradigm, with a subset of Veterans performing the task in an
fMRI scanner.
Once validated as a specific, objective phenotypic target for GABA modulation in HA-PTSD, RAMP
dynamic inhibition will be used in future clinical trials of novel agents that modulate GABA signaling (without
the downsides long-term benzodiazepines). The ultimate goal is to develop a clinical test to target treatments
to individual Veterans, thus improving treatment outcomes in this population.

Public health relevance
A substantial majority of Veterans with posttraumatic stress disorder (PTSD) continue to suffer even with the best current medications. Progress in developing more effective medications is hampered by the substantial variability within Veterans with PTSD, meaning the most effective medication likely varies from individual to individual. New scientific tools to help identify distinct subgroups of Veterans with PTSD who are likely to respond to specific medications could help improve treatment in this population. Research has indicated that a specific subgroup of Veterans with PTSD with a high level of anxious arousal may benefit from medications which boost signaling of the neurotransmitter gamma-aminobutyric acid (GABA). This project aims to validate a clinical test to identify these individuals using new computational and neuroimaging methods combined with the medication lorazepam, a positive GABA modulator. The ultimate goal is to use these methods in future clinical trials of new medications to target the best treatments to individual Veterans with PTSD.